Molecular Mechanism of Brown Adipose Tissue Regression

Abstract
Our preliminary data demonstrates that in both Adipoq and UCP1-specific Stx4 knockout mice results in
the activation of pyroptotic brown adipocyte cell death through the NLRP1 (NOD-like receptor protein 1)
signaling pathway. In parallel, brown adipose function and to a lesser extent mass declines during aging and
this age-associated decline in BAT thermogenesis occur concomitant with the induction of pyroptosis.
Furthermore, in both modes the regression of BAT results in the reduction in insulin sensitivity, energy
expenditure and cold tolerance that can be reversed by over expression of Stx4 in brown/beige adipocytes
(UCP1-Stx4 transgenic mice) or by blocking of pyroptosis using an inhibitor of caspase 1. In addition, aged and
Stx4 knockout mice have reduced protein levels of the cell survival receptors Ntrk3, a brown adipocyte
selective tyrosine receptor kinase within brown adipose tissue. Based upon these data, we are proposing a
multi-principal investigator (MPI) application to understand the molecular basis for the decline in brown adipose
tissue mass and function during the normal development of aging and the functional/physiological
consequences of preserving brown mass and function, in terms of energy balance, insulin sensitivity and
metabolic homeostasis. In this proposal, we will determine 1) the specific pathways and signaling events
responsible for brown adipocyte pyroptosis and functional consequences of preserving BAT using
both pharmacological and genetic interventions; 2) the functional role of the neurotropic tyrosine
receptor kinase Ntrk3 in regulating BAT mass, function and brown adipocyte pyroptosis; and 3)
changes in tissue cellular identity and its role during age-dependent BAT dysfunction and regression.
The findings obtained from this proposal will then allow to develop strategies to prevent age-dependent
regression of BAT that will likely provide a more tractable and effective therapeutic approach than the induction
of beige adipose tissue to improve glucose metabolism, increase energy expenditure and prevent weight gain.

Public health relevance
Narrative: Currently, a substantial effort is focused on understanding the mechanisms regulating the induction of thermogenic beige adipocytes as a potential therapeutic target for increasing energy expenditure to reduce and/or prevent obesity and insulin resistance. Although humans have the capacity to induce thermogenic adipocytes, only 50% of adolescents and 10% of adults display cold inducible beige/brown adipocytes. In contrast, all humans are born with brown adipose tissue that begins to decline during the first decade of life and continues to decline throughout the normal lifespan. Similarly, brown adipose depots in mice decline both in mass and function starting at approximately 8-12 months of age and continue to decline throughout their remaining life span. Our preliminary data indicate that the decline brown adipose tissue mass and function results the activation of a Nlrp1 pyroptosis cell death pathway that is the focus of this new grant proposal.